Multisensory integration and self-motion perception in primate vestibular cortex

Project Summary
In vertebrate animals, the vestibular system (primarily known as the “balance system” of the brain) interprets
head-movement and orientation signals to provide organisms with a sense of self-motion. The vital contribution
of vestibular system to reflexive control of posture, gaze, and gait is well characterized; however, far less is
known about the neural substrates underlying higher-order vestibular functions, such as the perception of self-
motion and the awareness of one's orientation in space. These functions rely on the cortical integration of
vestibular input with somatosensory and visual input. In non-human primates, the parieto-insular vestibular
cortex (PIVC) is uniquely suited to perform this multisensory integration. Unlike other vestibular-sensitive cortical
areas, PIVC has direct access to vestibular, somatosensory, and visual input from the thalamus; indeed, it is
hypothesized that other vestibular cortical areas receive their vestibular input from PIVC, thus making it a nexus
for higher-order vestibular function. Despite its hypothesized importance, extremely little is known about the
neural mechanisms by which PIVC integrates vestibular and extra-vestibular input, and whether this integration
is context dependent. For example, it is unclear whether PIVC neurons differentiate between vestibular input
generated during passive vs. active movements; such differentiation is seen in the vestibular nuclei and thalamus
and is thought to be essential for producing a sense of motor agency. To investigate these issues, I propose to
conduct high-density neurophysiological recordings in behaving primates during both passive stimulation and
actively generated head and whole-body movement. In Aim 1, I will investigate how PIVC integrates passively
applied vestibular and somatosensory input (Aim 1.1) and then vestibular and visual input (Aim 1.2). In Aim 2, I
will investigate whether PIVC differentially processes vestibular input during passive and active movement.
Specifically, I will examine how PIVC processes vestibular input generated during natural self-motion (i.e., self-
motion relying on sensorimotor input in the form of a head-turning task, Aim 2.1). I will then examine how PIVC
processes vestibular input generated during a learned, cognitively demanding motor task (Aim 2.2). In both aims,
I will determine how individual neurons in PIVC encode vestibular and extra-vestibular input, as well as how this
information is represented at the population level. The proposed experiments will resolve two questions which
are fundamental to understanding PIVC function: 1) How does PIVC integrate multisensory input to construct a
percept of self-motion? and 2) Is the processing of self-motion by PIVC neurons consistent with that required to
provide a sense of motor agency? Furthermore, the proposed experiments will determine how sensorimotor and
cognitive percepts of self-motion are represented in PIVC. This research will provide new insights into cortical
vestibular function and how it supports the higher-order processes that allow primates (both human and non-
human) to successfully perceive and navigate their environments.

Public health relevance
Project Narrative To successfully navigate its environment, an animal must be able to perceive both the orientation of its body in space and how its body moves through space; this perception requires integrating vestibular, somatosensory, and visual input in a contextually relevant manner. The proposed research will investigate how the parieto-insular vestibular cortex (PIVC) of non-human primates performs this multisensory integration and facilitates higher- order vestibular functions such as the perception of self-motion. This research will vastly improve our basic understanding of vestibular cortical function; in turn, this research will provide clinically relevant insight to physicians treating human patients who are experiencing dysfunctions related to vestibular cortical injury.